Transgenic Mouse Facility

PROJECT SUMMARY/ABSTRACT – SHARED RESOURCE: TRANSGENIC MOUSE FACILITY
The Transgenic Mouse Facility (TMF) directed by Kappes (NDC) provides the ability to introduce manipulated
genes and delete or modify endogenous genes in the germline of animals for FCCC members. This represents
a key technology for studying the role of specific genes of interest in normal development and cancer. The TMF
has developed a high level of expertise in using site-specific nucleases, in particular CRISPR/Cas9 technology,
for gene targeting in mouse embryos, which has led to generation of numerous novel animal models. Mouse
models generated by the TMF have uncovered important new roles for the targeted genes in normal mammalian
physiology and disease, directly supporting the center’s overarching pillar of innovation and discovery. The
centralized TMF allows users access to specialized technical expertise and equipment in a cost effective and
efficient manner. The TMF is utilized by investigators from all three research programs. The TMF also provides
services to investigators from the main Temple University Campus, which lacks its own TMF, and is quite heavily
utilized by Temple faculty, thereby contributing to integration with Temple. TMF services are also essential to
cancer investigators at two other nearby NCI designated Centers, the Wistar Institute and Thomas Jefferson
University, which also do not have their own transgenic facilities. User surveys indicate that mouse models
generated by the Facility have been instrumental in obtaining substantial new NIH funding (>7 major grants in
the last cycle), and high profile publications (Nature, Science, Nat. Immunol. etc.), demonstrating that the TMF
leverages extensive institutional and chargeback support to facilitate new grant support and ground-breaking
discoveries. The specific aims of the TMF are to: Aim 1. Generate transgenic and knockout mouse models for
the in vivo study of a broad range of biological processes, including cancer, development, cell signaling,
transcription and immunity. Aim 2. Provide support and advice for investigators during all phases of knockout
and transgenic mouse projects, including targeting strategy and vector design. Aim 3. Provide investigators with
mouse embryo cryopreservation services to protect irreplaceable mouse lines in the event of a catastrophic
event in the Laboratory Animal Facility (LAF), and to preserve mouse lines that are not in current use. The TMF
also rederives mouse lines with unknown/unacceptable health status to exclude harmful pathogens from the
LAF. Thus, the TMF recently rederived 23 mouse lines in a major effort to eliminate C. bovis from the LAF. The
TMF scored ‘Outstanding’ at the previous review and has serviced 29 FCCC members during this cycle (2019-
2023 (October) from all three Research Programs and supported 25 publications. For the 12 months ending
10/31/23, 86% of the users were peer-review funded FCCC members with 96% of the usage for services in
support of peer-review funded research.